Predictors of Influenza-Associated Absenteeism and Impact of Vaccination in a Cohort of Guatemalan Agricultural Workers

PROJECT SUMMARY/ABSTRACT
This is an application for a K23 Patient-Oriented Mentored Career Development award by Daniel Olson, MD.
The proposed research will assess the clinical and socioeconomic impacts of influenza in a cohort of
agricultural workers in Guatemala, evaluate clinical, biological, and socioeconomic predictors of influenza-
associated absenteeism, and measure the effectiveness of workplace-based influenza vaccine in reducing
disease and absenteeism.
Candidate. Dr. Olson is a board-certified pediatrician and infectious disease (ID) specialist who is an Assistant
Professor in the Department of Pediatrics at the University of Colorado (CU) School of Medicine, with a
secondary appointment in the Department of Epidemiology in the Colorado School of Public Health.
Training. Through hands-on mentored research, didactic coursework, and conferences/seminars, Dr. Olson’s
K23 Career Development aims include: 1) Develop and formalize skills in clinical trial design and
implementation, 2) Establish expertise in vaccinology, and 3) Obtain competencies to manage and develop a
high quality global health research site.
Mentors/Environment. Dr. Olson has assembled a diverse team of mentors, each with specific skills in his
proposed research and career development aims. Dr. Edwin Asturias, an Associate Professor of Pediatric ID
and Epidemiology at CU and the Jules Amer Chair of Community Pediatrics, will be his primary mentor. The
remaining mentorship committee includes Dr. Lee Newman, Dr. Kathryn Edwards, Dr. May Chu, and Dr.
Frederick Hayden, providing a diverse group of senior level mentors with broad experience and expertise.
Research. Low- and middle-income countries (LMICs) continue to suffer a disproportionate burden of
influenza disease. Workplace influenza vaccination programs may offer a cost-effective strategy to limit
absenteeism and lost productivity due to influenza. Agricultural workers represent an economically strategic
workforce in Latin America, and the drivers of illness-associated absenteeism, such as influenza, are unknown.
The CU research site in Guatemala has an established cohort of 2,706 agricultural workers from a nearby
banana plantation and a well-trained research team. To better understand the impact of influenza on
agricultural workers and the drivers of work absenteeism, we aim to 1) Evaluate the clinical and socioeconomic
impacts of influenza on a cohort of Guatemalan agricultural workers and determine predictors of work
absenteeism due to influenza, and 2) Measure the effectiveness of influenza vaccination on disease incidence,
absenteeism, and job performance in the same cohort. We hypothesize that influenza places a significant
burden on agricultural workers, that specific clinical, biological, and socioeconomic predictors may be
associated with greater absenteeism, and that a workplace-based influenza vaccine program will significantly
reduce clinical disease and influenza-associated absenteeism.

Public health relevance
PROJECT NARRATIVE The impact of influenza on agricultural workers in Latin America and the drivers of influenza-associated work absenteeism are largely unknown. We aim to study the impact of influenza in a large, existing cohort of agricultural workers in rural Guatemala, focusing on predictors of influenza-associated disease severity, absenteeism, and reduced work productivity. We will then measure the effectiveness of a workplace-based influenza vaccination program in reducing disease incidence, severity, and absenteeism.